Is the gut important in multiple joint osteoarthritis? A multimodal investigation in humans and pet dogs

Project Summary
The central hypothesis of this work is that increased intestinal permeability (IP), either directly, or via
related comorbidities, promotes the development and worsening of multi-joint osteoarthritis (MJOA).
Multiple joint osteoarthritis (MJOA; referring to OA in more than one joint site within an individual) is common
but understudied. MJOA is progressive, and as whole-body burden of OA increases, associated pain and
disability increases, and treatments are less successful. Despite the significant societal impact of MJOA, most
OA research remains focused on individual joints. There is an urgent need to understand the factors that
promote progression and worsening of MJOA. To address our hypothesis, our group has access to a large,
longitudinal cohort of human patients, and, uniquely, access to the naturally occurring MJOA model in pet
dogs. There are no rodent models of MJOA, but dogs with naturally occurring MJOA have similar disease
manifestations with more rapid progression compared with humans, making pet dogs an ideal model in which
to explore underlying mechanisms of MJOA and potential therapies. We have shown that inflammatory
mediators are related to overall burden of OA; these and other risk factors may at least partly derive from the
gut microbiome via increased intestinal permeability (IP; “leaky gut”). We have evidence that
lipopolysaccharide (LPS) and LPS-binding protein (LBP, reflecting increased IP and increased exposure to
microbial products), promote OA. Additionally, serum LPS in humans (and serum LBP in dogs) is positively
associated with the number of joints affected by MJOA. To further elucidate the role of IP as a mechanism in
MJOA, the proposed work will leverage human and dog studies: The JoCoOA, a longitudinal cohort of over
4000 Black and White men and women aged 45 and older; The Johnston County Health Study (JoCoHS), an
actively enrolling cohort (2019-, n~2000) including younger (35-70 years) and Hispanic individuals; and a large
cohort of readily accessible naturally occurring MJOA in pet dogs. Data from all three cohorts will be used to
address the following three aims. In Aim 1, we will determine cross-sectional associations between altered IP,
systemic inflammation, and radiographic and symptomatic MJOA in humans and pet dogs. Aim 2 will allow
identification of biomarkers predictive of development and worsening of MJOA and determine longitudinal
associations with markers of systemic inflammation and IP among JoCoOA participants and dogs. In Aim 3,
we will test the effects of a prebiotic on IP, the microbiome and MJOA symptoms by randomizing 70 dogs with
MJOA (from Aim 1) to receive either a fructooligosaccharide supplement or placebo for 3 months followed by
re-characterization of biomarkers of inflammation and IP. These studies will both verify the association
between increased IP and MJOA and robustly define biomarkers predictive of development and worsening
MJOA, laying the groundwork for mechanistic studies to understand how increased IP promotes MJOA and to
identify therapeutic targets, as well as provide means to identify at-risk individuals for preemptive management.

Public health relevance
Project narrative Osteoarthritis is an enormous and increasing public health problem that often involves multiple joints, and like many other complex chronic conditions, is not a single disease but a heterogeneous condition with various risk factors. This project will investigate the role of increased intestinal permeability (i.e., “leaky gut”) as a contributor to development and worsening of osteoarthritis at multiple joint sites in humans and a naturally- occurring osteoarthritis model in pet dogs, to advance our understanding of this nascent area of study, improve risk stratification, and lay the groundwork for novel therapeutic development. The proposed work, in a high- priority topic area for NIAMS (NOT-AG-19-037), represents a necessary step towards understanding risk factors and outcomes in this common and frequently debilitating condition.